ADM RESEARCH DEVELOPMENT AT THE UNIV OF TEXAS AT EL PASO

The University of Texas at El Paso Minority Institution Research Development Program (MIRDP) requests support for institutional development activities designed to remove impediments to ADM research and 9 research projects involving 13 faculty in two departments (Psychology and Social Sciences). A major institutional objective is to use MIRDP to support the development of a proposed Ph.D. program in Psychology which is designed to provide bilingual and bicultural psychologists. This will be accomplished by developing competitive research and establishing a strong record of involving minority students in applied ADM research. The individual research projects will investigate a broad range of ADM issues, many directly related to the bilingual and bicultural environment of El Paso. These include: 1) risk taking behaviors and perceived susceptibility to direct injury or harm in Black, Hispanic, and Anglo youth; 2) faculty and minority student stress in institutions of higher education; 3) event-related potentials in primates as a method to correlate EEG activities with subcortical generator potentials and human clinical syndromes; 4) event-related potentials as a technique to assess language problems and disorders in bilinguals; 5) acculturation and family support as predictors of adherence to mental health treatment regimens; 6) sex/ethnic differences in smoking, drug use, sexual behavior, and other risk-taking behaviors in Anglo and Hispanic populations, 7) evaluation of a pretrial intervention program for first-time DWI Anglo and Hispanic offenders; 8) the use animal models to develop better drug therapy for mental health related hyperkinetic disorders; and 9) evaluation of Alzheimer's disease in Hispanics and translation and norming of neuropsychological tests in Spanish.